DYNAMICS OF ENDOGENOUS GONADOTROPIN SECRETION IN CHRONIC RENAL FAILURE

The investigators have characterized in detail abnormalities in the pulsatile mode of LH, FSH, and prolactin secretion and clearance in men with chronic renal failure using computer-assisted pulse analysis and deconvolution methods. These studies have shown a hypothalamic component in the pathophysiology of hypogonadism in chronic renal disease. Women are now being studied also.